Post-doctoral Training Program in Cancer Metabolism and Tumor-host Interactions

Rutgers Cancer Institute of New Jersey (RCINJ) provides an outstanding environment for training in basic,
clinical, behavioral or population-based cancer research and brings together an exceptional group of
investigators organized in multi-disciplinary research teams focusing on a broad spectrum of cancer research.
The Cancer Metabolism and Growth (CMG) Program, at RCINJ has robust research strengths bolstered by
strong collaboration between researchers at Rutgers and our formal consortium partner Princeton University.
The proposed program leverages these unique research strengths and resources of RCINJ to provide training
in translational research in Cancer Metabolism and Growth and Tumor Host Interactions. The primary
goal of this T32 training program is to provide postdoctoral candidates with the highest quality training and
research experience so that they are competitive in developing research careers in academia, government,
and the private sector. To achieve this goal, trainees will engage in mentored cancer research, co-curricular
and professional career development activities for two years. Program candidates are Ph.D. recipients who
wish to develop careers in cancer research. The program will recruit a cohort of 2 new trainees each year from
year 1-5. Thus, the program will have 2 trainees in year 1 and 4 trainees in year 2 through 5 of the training
grant. High achieving post-doctoral fellows (evidenced by research productivity in the form of number of
publications, fellowship awards, presentations etc.), may be supported for an additional third year of training
through institutional funds. Faculty members with active, well-funded research programs and extensive
mentoring experience will support program trainees. All of the faculty mentors chosen for this program have
significant R01-level peer reviewed funding in tumor metabolism and host interactions focused research.
Experienced leadership team with track-record of research productivity and mentoring will ensure successful
implementation of the program. Both formative and summative evaluation will be integral parts of the proposed
program. We will annually track the educational and professional activities of trainees for at least 10 years
after completing research training. We will disseminate results from the comprehensive evaluation on the
program website. Additional dissemination will occur through articles published in peer-reviewed journals and
through presentations at regional and national conferences, by program staff as well as participants. Our
program benefits from the multi-disciplinary research environment and robust educational resources available
at RCINJ (the state's only NCI designated Comprehensive Cancer Center) as well as the consortium
relationship with Princeton University.
19

Public health relevance
The goal of this program is to train the next generation of translational researchers in cancer metabolism, growth, and host interaction mechanisms for an understanding of cancer at both tumor and host level. Better understanding of these mechanisms is critical for developing effective therapeutic strategies to target cancer.